Role of the integral membrane protease ZMPSTE24 in membrane protein biogenesis and virus-host cell fusion

PROJECT SUMMARY
A significant fraction of the eukaryotic proteome is composed of integral membrane proteins, most of which
are inserted and assembled at the endoplasmic reticulum (ER). The diverse biophysical characteristics,
topology, posttranslational modifications, and activities of these membrane proteins necessitate distinct cellular
pathways and numerous components to ensure their proper biogenesis and function. The goal of this project
is to define a new mechanistic role of the zinc metalloprotease ZMPSTE24 in membrane protein
biology. ZMPSTE24 has long been a research focus in my laboratory and is important for human health and
longevity through its established role in the proteolytic processing of farnesylated prelamin A, precursor of the
nuclear scaffold protein lamin A. Defects in this processing step lead to premature aging (progeria) diseases.
However, an intriguing new function for ZMPSTE24 in viral defense was recently discovered by others and
surprisingly does not require its catalytic activity: ZMPSTE24 confers potent antiviral activity against many
enveloped viruses through its interaction with a class of small membrane proteins called interferon-induced
transmembrane proteins (IFITM1, 2, and 3). The IFITMs block virus-host cell fusion by a mechanism that
involves “rigidifying” host cell membranes. As is the case for IFITMs, the overexpression of ZMPSTE24
robustly protects cells from infection by enveloped viruses, and its proteolytic activity is not needed in this role.
Furthermore, depletion of ZMPSTE24 in cells and mice cause them to succumb to viral infection. These
findings place ZMPSTE24 at an important position in the cell’s first line of defense against viral infection, likely
through a general cell biological role.
Here we hypothesize that ZMPSTE24 defines a central component in a known or new pathway for
membrane protein biogenesis (insertion, topology, stability/quality control, posttranslational
modification, or oligomerization), with IFITM3 as its substrate. Alternatively, ZMPSTE24 may facilitate
IFITM3’s membrane rigidifying function in some other way, directly by recruitment to IFITM3, or
indirectly by altering the composition or properties of the lipid bilayer. This project represents an exciting
new direction in my laboratory’s long-term studies of ZMPSTE24, inspired by the convergence of ZMPSTE24’s
newly discovered role in viral defense and the COVID-19 pandemic. Nevertheless, the studies we propose also
relate to earlier research in my laboratory on membrane protein topology, trafficking, and ER quality control.
Deciphering the antiviral role of ZMPSTE24 via the IFITMs presents an intriguing puzzle that we are primed to
solve. We expect the studies proposed here will uncover a new fundamental role(s) for ZMPSTE24 in
membrane protein biogenesis or membrane lipid composition or fluidity. Furthermore, insight into the
mechanism whereby ZMPSTE24 enables IFITMs to block virus-host-cell fusion could ultimately be harnessed
to develop a novel anti-viral drug.

Public health relevance
PROJECT NARRATIVE Proteins embedded in cellular membranes carry out critical cellular activities important in health and disease, but to do so they must be properly inserted into the membrane, move to the right place in the cell, and have the appropriate membrane environment to function. Here, we will determine precisely at which step a protein called ZMPSTE24 acts on one such membrane protein IFITM3, helping it to achieve its activity in blocking virus host-cell fusion, the first step of viral infection. Insight into the mechanism whereby ZMPSTE24 enables IFITM3 to attain its function could have general applicability to other membrane proteins and may someday be harnessed to develop an antiviral drug.